Ethical, Legal, and Social Implications of the Human Virome

PROJECT SUMMARY/ ABSTRACT
Advancing understanding of the human virome is a cross-institutional national priority. The National Institute of
Allergy and Infectious Diseases (NIAID) has a long-standing investment in U19 Genomic Centers for Infectious
Diseases, renewed in April 2024 (RFA-AI-23-015). Meanwhile, the Centers for Disease Control and Prevention
(CDC) recently funded 5 Pathogen Genomics Centers of Excellence to identify needs and opportunities for
genomics in the U.S. public health system (CDC 2023). Simultaneously, NIH’s Common Fund Human Virome
Program will support projects that will comprehensively capture the role of viruses in the human body (RFA-
RM-23-019). This investment trio reflects the enormous clinical and public health potential of expanding our
understanding of human viruses, providing unexpected insights into individual and population health.
Inevitably, viromics research teams will confront complex ethical, legal, and social implications (ELSI) of this
rapidly expanding area of science. In addition to standard concerns like risk, privacy, and broad consent,
viromics might raise concerns distinctive to this area of science, including conceptions of the “human virome”
and “viral colonization,” gaps in regulatory pathway for bacteriophage research, or public uncertainty generated
by complex genetic interactions among viruses, hosts, and vectors.
In this R21, we propose to focus on priority areas from NIAID and NHGRI: (1) support the integration of
bioethics work with genomic research in infectious diseases, analyzing ethical implications in the planning and
conduct of NIAID viromics research; and (2) significantly extend the focus of NHGRI’s ELSI and policy issues
that arise with the design and conduct of genetic and genomic research. Our project consists of three
interlocking aims with a planned expansion to an R01 proposal. (1) We will undertake a multidisciplinary
horizon scan based on an NIH-framework for governance of emerging technologies. This approach includes an
expert filtration of the scientific literature to select 5 high-priority topics in virome research and associated ELSI,
comparing ELSI of human genomics, microbiome, and virome. (2) Findings from Aim 1 will be developed into
vignettes of virome research including potential clinical and public health applications (such as use of
bacteriophages in clinical care and phylogenetics in hospital surveillance). Data will be collected from
interviews with experts from a variety of disciplines and professions, including responses to and expansions on
the 5 vignettes. (3) Using results from Aims 1 and 2, we will produce and disseminate vignette-based resource
guides to be used by viromics teams and trainees as they encounter ELSI. Resources will be disseminated
through professional communities of practice and the ELSIHub, a platform that supports multidisciplinary
resource sharing, including for lay audiences. In sum, through conceptual and empirical analysis, and vignette
development and dissemination, this project will advance ELSI resources and illuminate ELSI and policy
implications that arise in human virome research.

Public health relevance
PROJECT NARRATIVE Understanding the human virome (the genes of all the viruses that live in and on us) is a U.S. national research priority. We propose to study the complex ethical, legal, and social implications (ELSI) that human virome researchers face. We have three related aims: (1) we will identify in the scientific literature 5 high-priority virome research areas and associated ELSI, developing vignettes that highlight these challenges; (2) we will confirm our findings through 50 interviews with basic science and clinician professionals working in viromics research, obtaining responses to and expansions on the vignettes; (3) based on results from Aims 1 and 2, we will produce and disseminate case study resource guides to be used by viromics research teams and trainees as they encounter ELSI issues.